Short-Term Training Program to Increase Diversity in Health-Related Research

PROJECT SUMMARY
The purpose of this proposal is to provide opportunities for undergraduate students from under-represented or
disadvantaged backgrounds to engage in an intensive, summer research training experience. Individuals from
diverse backgrounds are under-represented in biomedical and behavioral sciences. While the underpinnings of
this issue are complex, the problem has been perpetuated in no small part due to major limitations in the
educational pathways of trainees from diverse backgrounds. As a reflection of our commitment to this issue,
the Division of Pulmonary and Critical Care Medicine has been running an NHLBI-funded program for students
from under-represented or disadvantaged backgrounds for the past 20 years, 15 of those as the current R25
program. We wish to build on this foundation and sustain this initiative. Our program was developed on the
premise that the principal barrier to diversity in science is not a lack of talent, but rather a lack of opportunity.
The program was created around an intensive research experience with an individual mentor, complemented
by activities important to building communication and networking skills, such as making presentations in journal
club and at a closing poster session, as well as seminars and workshops that address issues relevant to
career-building in biomedical sciences. To date, through this R25 we have trained 194 students. Of the 167
students that participated in our program and have now graduated from their undergraduate institution, 148
have been accepted to, enrolled in or received advanced degrees from medical/graduate school. In addition,
16 students are working full-time in research positions with plans to apply to graduate/medical school, bringing
the number of past participants actively engaged in the biomedical sciences to 98%. Of note, 111 students
continued to publish after their R25 participation. Many of these students are physicians, evidence of continued
engagement in research as they pursued medical training, creating an accomplished pool of physician
scientists. In pursuing funding through this R25 program, we have three principal goals. The first is to provide a
high-quality scientific experience to students of diverse backgrounds as a means of exposing them to, and
persuading them of, the excitement of careers in biomedical sciences. The second goal is to provide students
exposure to activities that will enhance their chances for success in biomedical careers, such as organizing
material for presentations and seminars on the mentee-mentor relationship. Finally, we hope to continue to
develop a network of contacts, role models and information that will help these individuals surmount historical
issues of access to improve entry and success. Over the past 15 years, we have demonstrated our
commitment to enhancing diversity in the biomedical sciences and success in expanding the pool of
underrepresented individuals pursing biomedical science careers. Through this renewal, we look forward to
extending this commitment and further broadening our impact.

Public health relevance
NARRATIVE The goal of this project is to continue the development and implementation of a training program designed to encourage and enable undergraduate students from under-represented and disadvantaged backgrounds to pursue biomedical research careers in areas related to heart, lung or blood pathophysiology. Our program was developed on the premise that the principal barrier to diversity in science is not a lack of talent, but rather a lack of opportunity. Thus, our program was built around an intensive research experience with an individual mentor, complemented by activities important to building communication and networking skills, such as making presentations in journal club and at a closing poster session, as well as seminars and workshops that address issues relevant to career-building in biomedical sciences.